THE PROCESS OF LYSOGENY

The assembly of the complex nucleoprotein arrays that govern DNA metabolism is often limited by the inherent stiffness of the duplex. The IHF protein of E. coli is representative of a group of proteins dedicated to overcoming this limitation by introducing points of DNA bending at strategic places in the genome. We have evaluated the degree to which non-specific DNA binding influences the biological availability of IHF protein. By combining in vitro measurement of affinity and in vivo footprinting we have determined that non-specific interactions severely reduce the effective intracellular concentration of the protein, thereby permitting high affinity IHF binding sites to serve as landmarks. We have also prepared co-crystals of IHF and one such specific binding site, opening the way for the determination of the molecular structure of this complex. In related work, we have shown that a one segment of DNA can be assembled by IHF and a recombination protein, Int, into two alternative architectures. By using the same IHF site but a different set of binding sites for Int, the 100 bp segment is thereby activated to undergo recombination with two different partners. Int protein catalyzes recombination of bacteriophage lambda using a topoisomerase mechanism. Abortive recombination can damage the host chromosome by trapping a covalent intermediate between Int and DNA; eukaryotic topoisomerases are subject to the same danger. We have discovered a novel phosphodiesterase activity that can function as a DNA repair enzyme for this damage.